Metagenomic surveillance of pathogen and antimicrobial resistance gene transmission in hospitalized neonates

PROJECT SUMMARY
Healthcare-associated infections (HAIs) are a major challenge in neonatal intensive care units (NICUs),
resulting in prolonged hospital stays, and preventable morbidity and mortality. Infections in the NICU are more
likely to be resistant, with the most common infections being central line-associated bloodstream infections,
surgical site infections, skin and soft tissue infections, and pneumonia. Current approaches to understanding
HAI and antimicrobial resistance (AMR) are largely dependent on bacterial culture, which may fail to detect
carriage of outbreak-associated pathogens, and which can be falsely negative in the setting of antibiotic pre-
treatment or fastidious organisms. In contrast, metagenomic next-generation sequencing (mNGS) offers a more
comprehensive view of the neonatal microbiome, including viral and bacterial microbes, and the associated AMR
genes. These proposed aims will evaluate the potential of mNGS surveillance to provide novel insights into
pathogen transmission and AMR acquisition, thereby better informing hospital infection prevention and AMR
control strategies.
This proposal leverages mNGS to study a prospective cohort of NICU patients sampled weekly with nasal
and skin swabs, paired with weekly environmental surface swabs of patient rooms to study the dynamic
exchange of pathogens and AMR genes in the NICU with the following specific aims: Aim 1: Identify nosocomial
transmission of viral and bacterial pathogens in the NICU through prospective mNGS surveillance of the nasal
and skin microbiome. Aim 2: Characterize the microbiome and the associated AMR genes of environmental
surfaces in patient rooms and assess the microbial exchange between patients and their surroundings. Aim 3:
Determine the impact of antibiotic exposures on the neonatal nasal and skin microbiome and the associated
AMR genes. Findings from this research will provide critical preliminary data to support future R01-funded
investigations including: 1) utilizing mNGS for real-time pathogen surveillance in healthcare settings to enable
more timely infection prevention interventions, and 2) validating AMR findings through a multi-center study to
inform antimicrobial stewardship priorities.
The candidate's long-term career goal is to become an independently funded physician-scientist
specializing in advanced genomic and metagenomic technologies to address the dual public health threats of
HAI and AMR. The research is well supported by collaborations with UCSF's Medicine and Pediatric Infectious
Disease Divisions, the Hospital Epidemiology and Infection Prevention program, and the Chan-Zuckerberg
Biohub. Through this K23 award, the candidate will receive practical and didactic training in study design,
biospecimen management, computational analysis of high-dimensional metagenomic data, and infection
prevention, enabling the candidate to establish a unique research niche focused on harnessing mNGS
technology to inform and enhance infection prevention and AMR control strategies.

Public health relevance
PROJECT NARRATIVE Healthcare-associated infections in neonatal intensive care units lead to significant morbidity and mortality, and are often caused by antimicrobial resistant pathogens. This proposal will use metagenomic next-generation sequencing in novel ways to track pathogen transmission, identify environmental reservoirs of infection, and understand acquisition of antimicrobial resistant microbes in hospitalized neonates. Together this work leverages innovative metagenomic sequencing tools and analyses to advance infection control approaches and curb the spread of drug-resistant infections.